MR Fingerprinting for Epilepsy

Abstract
Approximately 40% of patients with pharmacoresistant focal epilepsy undergoing presurgical evaluation have no
identifiable lesions on the MRI. In these patients, detection of subtle epileptic lesion is directly linked to the odds
of seizure-free outcome. Focal Cortical Dysplasia (FCD) is frequently the underlying pathology in MRI-negative
epilepsies. FCD lesions are often missed on conventional clinical MRI, because they have subtle MRI
characteristics and only differ slightly from normal cortex. The limitations of conventional structural MRI to detect
FCD lesions can be addressed by MR Fingerprinting (MRF). This novel technology allows highly efficient
quantitative MRI scan in a clinically feasible time on commonly used clinical scanners. The tissue property maps
generated by MRF are specific to cell structure and micro-environment changes that are particularly relevant for
FCD. Our previous R01 project centered on the development of a 3T MRF framework specifically designed for
patients with epilepsy and FCD. In this renewal proposal, we aim to address critical steps necessary for full
translation of the all-quantitative MRF framework to make a real clinical impact. In Aim 1, we will develop a fully
automatic, fast, and traceable imaging pipeline for 3D MRF with enhanced motion robustness and GPU-based
online reconstruction within 5-minute post-scan turnaround. This end-to-end workflow from acquisition to
radiology reading room will make MRF available to every patient undergoing presurgical evaluation. Assisted by
this workflow, we will conduct a neuroradiologist consensus review to assess the diagnostic yield of MRF. In Aim
2, we will develop robust MRF machine/deep-learning (ML/DL) models to predict the epileptogenic zone, utilizing
data from patients who have achieved post-operative seizure freedom. We will delineate the epileptogenic zone
based on the regions included in surgery shown by coregistered post-operative MRI. Validation will be performed
on a withheld data set not used for the model training. Our central hypothesis is that the quantitative MRF
framework will detect subtle tissue abnormalities with high epileptogenicity, and the removal of these
abnormalities will be associated with favorable postoperative seizure outcomes. Our developments will
lead to significant improvements in seizure outcomes for both adult and pediatric patients suffering from disabling
pharmacoresistant epilepsy. Taking another leap, in Aim 3, we seek to leverage the unique availability of SEEG
and MRF data in the same individual, to clarify the intricate relationship between MRF signals and their
electrophysiological underpinnings on SEEG. We will deliver anatomo-functional atlases as an open-source tool,
comprising two precisely co-localized layers of information: a quantitative MRF tissue property layer, and an
SEEG spectra electrophysiological layer, with interrelationships between these two layers in both normal and
FCD-affected brain regions. These developments will advance future imaging-pathological-electrophysiological
studies in the normal brain, epilepsy and other neurological conditions.

Public health relevance
Project Narrative In this project, we aim to improve postoperative seizure outcomes for patients with pharmacoresistant focal epilepsies and nonlesional MRI, by incorporating cutting-edge MR Fingerprinting (MRF) technology into clinical practice. We will use MRF images to train machine/deep-learning models to identify epileptogenic brain regions, thereby refining individualized surgical plans. Moreover, by merging MRF with SEEG data from our patients, we will elucidate the complex interplay between quantitative MR imaging, pathology, and brain physiological activity.